Combining senescence-inducing and senolytic agents to improve melanoma therapy

Contact PD/PI: Vilgelm, Anna E
Project Summary
Metastatic melanomas are aggressive tumors that respond poorly to chemotherapy and radiation and
promptly acquire resistance to targeted therapy. While immune checkpoint inhibitors (ICIs) can induce
sustained melanoma remission, nearly half of patients are intrinsically resistant to ICIs, in part because their
tumors are too large to be cleared by the immune system or are immunologically “cold” and lack immune
recognition necessary to generate anti-tumor T effector cells. Our preliminary data show that senescence-
inducing therapy enhances melanoma-cell intrinsic pro-inflammatory program driven by transcription factor NF-
κB. We identified the RIG-I-Like Receptor (RLR) pathway as a candidate NF-κB inducer. This pro-inflammatory
program involves enhanced antigen presentation and secretion of chemokines that recruit antigen-presenting
cells into the tumor. We also found that senescent cells overexpress checkpoint molecules PD-L1 and Galectin
9, which can inhibit T cells by binding their inhibitory receptors PD-1 and TIM-3, respectively. This suggests
that senescence-inducing therapy can enhance recognition of tumor antigens while targeting senescence-
specific immune checkpoints can promote adoptive T cell responses against these antigens.
Despite its immunogenic properties, therapeutic application of senescence-inducing agents is complicated
by the reports that persistent senescent cells may promote tumor metastasis, relapse, and chemo-resistance.
Here we hypothesize that we can safely improve melanoma immunogenicity by inducing tumor cell
senescence for a limited time, followed by elimination of persistent senescent cells using senolytic drugs that
specifically kill senescent cells. This novel therapeutic approach is expected to be effective by: 1) directly
blocking tumor cell growth and survival, 2) activating RLR-mediated tumor cell intrinsic immuno-stimulatory
signals, and 3) making tumor cells vulnerable to inhibitors of PD-L1/PD1 and Galectin 9/TIM3 immune
checkpoints. Three specific aims will examine these mechanisms. In the first aim we will establish the optimal
dosing schedule for combined senescence-inducing and senolytic therapy and determine the direct anti-tumor
efficacy in an immune-deficient mouse model. A pre-clinical trial using our extensively characterized melanoma
PDXs will be conducted to estimate response rate to senescence-inducing and senolytic drug combinations
and to identify response-predictive biomarkers. Second aim will investigate the mechanisms whereby
senescence-inducing and senolytic therapy facilitates the innate immune sensing of tumor focusing on the role
of RLRs. We will examine whether deficiency in RLR signaling can abrogate NF-κB activation, chemokine
secretion, and immune cell recruitment into senescent tumors. Aim three will determine if senescence-inducing
and senolytic therapy augments immune checkpoint inhibitor (ICI) responses. We will utilize anti-PD-L1 and
anti-TIM3 agents to target senescence-cell specific immune checkpoints. These studies will provide a
preclinical basis for clinical development of rational combinations of senescence-inducing and senolytic agents.
Page 6
Project Summary/Abstract

Public health relevance
Contact PD/PI: Vilgelm, Anna E Project Narrative The focus of this project is on pre-clinical development of a novel therapeutic concept where melanoma tumor growth is controlled by directly targeting tumor cells and by making them easier targets for the anti-tumor immune response. This research will improve our understanding of tumor-host interactions, and enable effective therapeutic modulation of these interactions. This work should to have a profound impact on the survival of metastatic melanoma patients by advancing a novel therapy for patients who fail to respond to standard of care treatments. Page 7 Project Narrative